Emerin regulation of myogenic differentiation: implications for muscle disease

X-linked Emery-Dreifuss muscular dystrophy (EDMD1) is an inherited disorder characterized by progressive
skeletal muscle wasting, irregular heart rhythms, and major tendon contractures. EDMD1 is caused by
mutations in emerin, an inner nuclear envelope protein, but the molecular mechanisms for the pathogenesis
remains unknown. We do know that the skeletal muscle pathogenesis in EDMD1 is related to impaired muscle
regeneration due to compromised muscle stem cell differentiation. During differentiation, the genome in muscle
stem cells is dynamically reorganized to coordinate the temporal expression of the differentiation transcriptional
program. Our previous data showed the functional interaction between emerin and histone deacetylase 3
(HDAC3) contributes to regulating this genomic reorganization. Our working hypothesis is that the dynamic
interaction between emerin and HDAC3 regulates the genomic reorganization necessary for differentiation. We
further predict abrogation of this interaction by EDMD1-causing emerin mutations disrupt this genomic
reorganization to block transcriptional reprogramming. To test this hypothesis, we will: Aim 1. Determine how
emerin binding to HDAC3 organizes repressed myogenic loci at the nuclear envelope (NE); Aim 2. Evaluate
the dynamic organization of myogenic loci at the NE during differentiation and its dysfunction in EDMD1; and
Aim 3. Test if shifting H4K5 acetylation dynamics by treatment with histone acetyltransferase (HAT) inhibitors
or HDAC3 activators rescues EDMD1 differentiation. Completion of these studies will provide mechanistic
insight into the impaired muscle regeneration underlying the skeletal muscle pathogenesis of EDMD1. These
studies will also significantly impact other neuromuscular diseases because muscle regeneration is important
in many of these diseases. Completion of these studies will also have a broader impact because repairing
tissue damage throughout the body uses resident stem cells that require the coordinated temporal expression
of differentiation genes, which is dictated by dynamic genomic reorganization.

Public health relevance
How mutations in the gene encoding emerin cause Emery-Dreifuss muscular dystrophy remains unknown; however, the skeletal muscle pathology is caused by the failure of skeletal muscle to regenerate after injury. The studies proposed here will test how emerin regulates the dynamic genomic reorganization during myogenic differentiation to control the coordinated temporal expression of differentiation genes. Understanding how this dynamic genomic organization at the nuclear envelope is regulated to ensure proper transcriptional reprogramming upon muscle stem cell activation and differentiation will facilitate the development of therapies for muscle disease.